Validation of Immune Dysfunction in Model of Social Stress: Implications for Major Depression Disorder in Veterans

Project Summary/Abstract
At least 30% of Afghanistan and Iraq veterans are affected by Major Depressive Disorder (MDD) and 20% are
affected by post-traumatic stress disorder (PTSD) and other stress-related mood disorders. Currently existing
pharmacological treatments elicit temporary remission in <50% of patients; thus, there is an urgent need for
novel therapeutic approaches to target MDD and psychological stress-related mood disorders. The prevalence
of MDD is two- to threefold higher in patients with cardiovascular disease and MDD is associated with 80%
increased risk of cardiovascular morbidity and mortality. Clinical studies report higher levels of circulating pro-
inflammatory cytokines in patients with MDD and has been replicated in preclinical animal studies of
depression. Individual differences in the modulation of cytokine release (most notably IL-6) are associated with
susceptibility vs. resilience to chronic social stress in mice. Chronic inflammation and increases in circulatory
pro-inflammatory cytokines associated with stress-induced depression is linked with atherosclerotic plaque
formation, progression, and rupture, likely contributing to the pathogenesis of cardiovascular disease. Indeed,
immune modulatory approaches to neutralize inflammatory cytokines in the periphery produce antidepressant-
like behavioral effects following Chronic Social Defeat Stress (CSDS) in mice as well as in humans with
depression and chronic inflammation. The concept of resilience, the ability to maintain normal psychological
and physical functioning to avoid serious mental illness has topic of significant interest in Veterans during and
post-deployment after exposure to psychological stress.Recently, CSDS-associated depression has been
linked to impairment of the blood brain barrier (BBB), a series of protective layers including endothelial cells
and astrocytes that plays a critical role in maintaining vascular impermeability between the periphery and brain
parenchyma. The proposed validation studies implicate that impairment of the BBB may be causally
associated with stress-induced mood disorders. In particular, we will validate and expand our understanding
how stress influences the region-dependent impairment of the BBB in stress-induced mood disorders, as
previously reported by our collaborators Scott Russo, Anne Schaefer, and Miriam Merad in their publication
“Social stress induces neurovascular pathology promoting depression”. Using a well-characterized CSDS
model of psychological stress in mice that recapitulates many of the symptoms of MDD including social
withdrawal, anhedonia, and anxiety, we will explore through novel technological approaches how chronic
psychological stress impairs the BBB. In particular, we will utilize a novel endothelial-specific Translating
Ribosome Affinity Purification (TRAP) mouse to explore stress-induced transcriptional patterns in multiple
mood-related brain regions to determine transcriptomic patterns to psychological stress. To further explore how
psychological stress impairs the BBB, we will utilize an innovative mass cytometry (CyTOF) to determine the
immune cell profiles in the periphery and brain tissue of susceptible vs. resilient mice and understand how
psychological stress mobilizes the innate immune system and causes infiltration of cytokines into the brain.
In summary, the proposal in this Merit Review Award for Validation Studies is of importance to Veteran Health.
This VA Merit Review Award is to validate recent findings by our collaborators showing that psychological
stress in a model of depression impairs BBB permeability and expand our knowledge into how stress induces
region-specific endothelial gene expression changes, leading to vascular damage and depression-linked
chronic inflammation. The findings of our studies will provide evidence for preclinical studies for novel
therapeutic approaches for treating stress-related MDD for Veterans.

Public health relevance
Project Narrative At least 30% of Iraq and Afghanistan veterans are affected by Major Depressive Disorder (MDD). Conventional pharmacological treatment produces temporary remission in <50% of patients. Thus, there is an urgent need for novel therapeutic approaches to target MDD and psychological stress-related mood disorders. MDD is associated with damage to the blood brain barrier (BBB) and damage to the epithelium, potentially allowing for infiltration of cytokines into the brain and maladaptive inflammatory responses to stress. In this study, we will identify regional gene expression and epithelial structural changes in response to psychological stress to offer potential innovative therapeutic approaches to prevent stress-related depression and mood disorders.